Mechanisms of robustness in organogenesis

Mechanisms of robustness in organogenesis
Project Summary/Abstract
The size and shape of an organ are essential for its function. Developing organs are remarkably robust,
meaning that they reproducibly grow to reach the same size and shape in each individual, despite variability in
cell growth and division, the inherent stochasticity of gene expression, and environmental fluctuations. The
systems-level mechanisms generating this robustness remain largely unknown. When developmental
robustness mechanisms in humans are disrupted and these perturbations are not buffered, organ size and
shape become variable, resulting in birth defects. My laboratory has focused on deciphering the systems-level
mechanisms that yield robustness in organ size and shape. We have established the Arabidopsis sepal, the
outermost green leaf-like floral organ, as a model system for studying robustness because we can image the
development of living sepals, track the cell lineages, and quantify the cell growth, division, and expression
levels of fluorescent markers in the cells throughout the development of the sepal, making it a powerful system
for elucidating how cells give rise to the organ size and shape. Our interdisciplinary approach that combines
advanced live imaging, genetic engineering, advanced image processing, and computational modeling,
uniquely enables us to gain mechanistic insights that reflect both biochemical and mechanical factors of
perturbation and robustness. Previously, we isolated the first sepal robustness mutants, and we demonstrated
that robustness of size and shape is generated through: (1) precise initiation of organ development, (2)
averaging of local fluctuations in cellular growth, and (3) coordination of growth across cell layers of the organ.
However, the molecular details of how these mechanisms maintain robustness are largely unknown. Over the
next five years we will focus on three complementary and synergistic research areas to further elucidate these
robustness mechanisms. First, we will determine how initiating of the development of the organ from the stem
cells is robust to stochasticity in hormone signaling. The plant hormone auxin is crucial for organ initiation and
our preliminary data suggests auxin signaling is noisy early in development but becomes stabilized into four
regions which give rise to four sepals. We will quantify intrinsic versus extrinsic noise in auxin signaling and
determine the function of DRMY1 in dampening noise. Second, we will elucidate how organ growth is robust to
cellular growth fluctuations. We will test the role of microtubules and intercellular mechanical signals in
spatiotemporal averaging of cellular noise to produce robust organ shapes. Third, we will determine how
growth coordination mechanisms produce organ shapes that are robust to mechanical conflicts caused by
differential growth rates across cell layers. Our work points to a role for the mobile transcription factor
ASYMMETRIC LEAVES 2 and microRNAs that can move from cell to cell through plasmodesmata (small
pores connecting cells) in coordinating cell growth, which we will test. Our combined results will reveal
mechanisms and principles of robustness that together produce highly reproducible organ sizes and shapes.

Public health relevance
Project Narrative The development of all complex multicellular organisms, from plants to humans, is robust in that it reproducibly produces organs of the correct size, shape, and function despite the inherent cell to cell variability and inevitable physiological and environmental stresses of everyday life. This project takes a quantitative biology strategy, combining genetics, advanced live imaging, computational analysis, and modeling to elucidate the mechanisms enabling robust organ size and shape. Through acquiring a deep understanding of the fundamental mechanisms and principles that generate robustness, we will gain insights that not only clarify normal development, but also guide development of new therapies to address birth defects or cancer (i.e., conditions wherein this robustness breaks down).